Pennsieve: Impactful Multimodal Data Sharing for Epilepsy Research

Summary
Epilepsy affects over 70 million people globally and more than 3.6 million Americans, 1/3 of who are not
controlled by medication. While new technologies like laser ablation, implantable devices, high bandwidth
intracranial EEG (iEEG), and multimodal imaging have improved therapies, meaningful data sharing is lacking
which limits clinical progress and translational research. There is a tremendous need to aggregate, share and
collaborate on increasingly large and complex multimodal data from patients with medication-resistant epilepsy
to advance these efforts, but a lack of novel mechanisms to share and explore these data in a meaningful way.
Our central hypothesis is that a scalable, self-sustaining Epilepsy Data Ecosystem (EDE), which integrates
multi-modal datasets and is responsive to the changing needs of the epilepsy community, will dramatically
accelerate translational research and impact clinical care. The EDE will also accelerate the fields of Machine
Learning, Neuroscience and Computer Science, communities that depend upon large, multimodal data from
these patients for their research. Over the past 14 years our group has focused on building tools and community
to accelerate translational epilepsy and neuroscience research through two major efforts: (1) through our open-
source platform iEEG.org, for sharing data and computational tools in epilepsy. Seeded by a grant from NINDS
from 2009-2013 and supported by a group of over 200 scientists focused on Engineering and Epilepsy Research
(the ICTALS group), the platform now has almost 6,000 users and is self-sustaining, paid for by groups who use
it for their research needs. It shares over 1,000 published data sets free of charge, and it has generated scores of
publications. Advances to care, data standards and platform technologies as well as the significant increase in
data volume require that iEEG.org be updated. (2) Led by Dr. Joost Wagenaar, The Pennsieve Platform was
independently developed over the last 7 years as an open-source, cloud-based data management and sharing
platform for large volume, multi-modal data in the Neurosciences, with a focus on standards, scalability, and
sustainability. It is currently used as the data core for several NIH programs (e.g. SPARC and REJOIN) and is
ideally suited to replace iEEG.org as the next generation repository for multimodal data in Epilepsy research.
Our goals for this proposal are: (1) To migrate all data, tools, and users from iEEG.org to Pennsieve, to ensure
continued impact of iEEG.org public datasets by updating the data to adhere to current standards, (2) To tailor
Pennsieve to the Epilepsy Community's needs, to develop seamless mechanisms for submitting, finding,
sharing, accessing, and publishing high impact Epilepsy Datasets in line with all FAIR requirements and
standards in the age of big integrated data, (3) To build community and prospective data contributions to the
EDE through educational workshops, seminars and web content, and (4) to leverage Pennsieve's workflows and
existing model to ensure sustainability. This project leverages an established collaboration between
investigators across Medicine and Engineering at Penn, and the International Epilepsy Community.

Public health relevance
Project Narrative This project will leverage the University of Pennsylvania's open-source platform, Pennsieve, to create an international Epilepsy Data Ecosystem, a resource to accelerate collaborative research on Human Epilepsy. This repository will take in and share high-impact, multi-modal data sets from leading clinical centers and make them easy to discover, share and analyze to improve patient care and develop new technologies. The project replaces ieeg.org, and prospectively take in data from contributors around the world, as a scalable and sustainable repository for epilepsy research.